The Gut Microbiome, Lifestyle, and Colorectal Neoplasia

PROJECT SUMMARY / ABSTRACT
Colorectal adenoma is the precursor for the vast majority of colorectal cancers (CRCs). We and others have
shown that lifestyle factors play an important role in the colorectal adenoma-carcinoma sequence. Western diet
and obesity have been associated with increased risk of colorectal neoplasia, whereas physical activity and
regular use of aspirin has been associated with lower risk. Emerging evidence indicates that gut microbes are
pivotal in integrating environmental cues with host physiology and metabolism, and disturbances in the gut
microbiota have been linked to colorectal neoplasia and other chronic conditions. Although a role for microbiota
in carcinogenesis is gaining acceptance, available human data are largely cross-sectional and do not lend
themselves to interrogation of whether microbes are intrinsically oncogenic (i.e. “drivers”) or a consequence of
tumorigenesis (i.e. “passengers”). Thus, there is a high unmet need to conduct a large, prospective study to
examine the network of interactions between the gut microbiota and their associated metabolites, lifestyle
factors, and colorectal neoplasia within diverse populations. We propose to characterize the gut microbiota
leveraging stool samples currently being collected from women and men enrolled in the ongoing Nurses’ Health
Study (NHS)II (n=25,000) and the Southern Community Cohort Study (SCCS) (n=8,500). Participants have been
followed since 1989 (NHSII) and 2002 (SCCS) and have provided validated, updated assessments of diet,
lifestyle, medication use, and diagnoses of chronic diseases with high follow-up. After stool collection, we will
continue to follow these cohorts and document the incidence of adenoma. We will test the hypothesis that
lifestyle factors linked with CRC are associated with a higher abundance of immunomodulatory and tumor-
permissive gut microbes and a depletion of microbes that protect against tumorigenesis. In turn, these gut
microbiome patterns and their associated metabolites will be associated with risk of adenoma on follow-up
colonoscopy. To provide additional evidence of causality, we will examine if the gut microbial features in baseline
stool samples linked to adenoma will be stable in stool samples collected after adenoma development and is
associated with gut microbial features and expression of human host genes and pathways in adenoma tissue.
By leveraging ongoing, already funded stool collections within a cohort of predominantly white women (NHS II)
and a cohort of women and men with a high proportion of African-Americans (65%) and the socioeconomically
disadvantaged (SCCS), our proposal is highly cost-efficient and will offer rigorous and reproducible results
relevant to diverse populations. Our established multidisciplinary team proposes the next critical step in
understanding the intricate relationship between the gut microbiota, lifestyle factors and colorectal neoplasia in
diverse populations. This investigation will illuminate significant insights into the etiopathogenesis of CRC and
launch novel research into CRC prevention through gut microbiota-targeted diagnostics and therapeutics.

Public health relevance
PROJECT NARRATIVE Colorectal adenoma is the precursor for the vast majority of colorectal cancers, the second leading cause of cancer death in the U.S. Gut microbes are pivotal in integrating colorectal cancer-associated lifestyle factors, including Western diet, obesity, physical activity, and aspirin use, with host physiology and metabolism; in turn disturbances in the gut microbiota have been linked to colorectal adenoma and cancer. Understanding the intricate relationship between lifestyle factors, the gut microbiota, and colorectal neoplasia will illuminate significant insights into the etiopathogenesis of colorectal cancer and launch novel research into cancer prevention through gut microbiota-targeted diagnostics and therapeutics.